Effects of Extreme Temperature on Aging Populations in the United States: AGeographically Granular Assessment of Present and Future Impacts by Race and Ethnicity

PROJECT SUMMARY
The overall objective of the proposed research is to estimate the present and future burden of extreme
temperature in a geographically detailed manner for the US. Extreme temperature risk will be assessed on a 4x4
km grid for the contiguous US and roll into socio-demographic and -economic information available on the census
tract and county level. The main emphasis lies in understanding how risk increases across the lifespan and
quantifying the expected impact in aging populations. Understanding how extreme temperature effects are
modified by other factors such as socio-demographic or socio-economic characteristics, pre-existing health
conditions, and air pollution etc. is another key aim of the proposed work. In a previous study, the PI estimated
that approximately 124,000 (95% UI: 105,000-145,000) deaths in the US in 2019 occurred due to exposure to
non-optimal temperature. This renders temperature the leading environmental risk factor in North America,
currently contributing to more deaths than air pollution. Cold exposure, in particular, adds to this high burden,
but substantial heat-related effects occur in states such as Arizona, Texas, or Louisiana. With temperatures
rising, the significance of heat-related deaths is likely to increase. In addition, population aging in the US, with
the population aged 65 years and above expected to double by 2060, is potentially aggravating the impact of
extreme temperature. While several studies have assessed temperature impacts on all-cause or broad
categories of disease, there is no systematic assessment of the impact of extreme temperature on cause-
specific mortality or of the role of risk modification, especially by age. Furthermore, most related studies have
conducted risk assessment in select locations, mostly individual cities, but spatially detailed continuous
assessments across regions are lacking. Here, we suggest research that is driven by three hypotheses and
centered around three aligning research aims. In Aim 1, we will derive all-cause and cause-specific risk functions
for extreme high and low temperature across the lifespan and estimate county-specific burden. In Aim 2, we will
project future impacts of extreme temperature-related disease using climate and population change scenarios.
Finally, in Aim 3 we will assess the risk reduction potential associated with interventions to reduce temperature-
health risk and provide regional risk reduction guidance. Detailed estimates allow identifying priority areas and
target specific population and patient groups. The proposed work draws from the extensive data and
infrastructure available at IHME and builds upon work previously conducted within the Global Burden of Disease
study. Results will be published in scientific journals and via an online visualization tool, allowing the scientific
community, as well as non-technical audiences, the media, and policy- and decision-makers to view and utilize
the results. To ensure effective communication and policy translation of results, the research team is supported
by a policy advisory panel and the IHME Global Impact group.

Public health relevance
PROJECT NARRATIVE Research conducted through the Global Burden of Disease study, including work by the PI of this application, estimated that approximately 124,000 (95% UI: 105,000-145,000) deaths in the US in 2019 occurred due to exposure to non-optimal temperature, which renders temperature the leading environmental risk factor in North America, currently contributing to more deaths than air pollution and occupational risks. For the suggested study, we hypothesize that risk is modified by age, socioeconomic condition, and preexisting health status as well as air pollution, and varies sex, by race and ethnicity. We propose a research strategy to estimate the current and future burden on a geographically granular level through three Specific Aims: 1) derive all cause and cause- specific risk functions for extreme high and low temperature in diverse aging populations and estimate attributable burden based on a 4x4 km temperature grid; 2) project future impacts of extreme temperature-related disease using climate and population change scenarios; and 3) assess risk reduction potential associated with interventions to reduce temperature-health risk and provide regional risk reduction guidance.